Enhancing Collaboration between the Engineering & Physical Sciences and Biomedica

The National Cancer Institute (NCI) is partnering with the National Science Foundation (NSF) to promote the joint sponsorship of proposals that enhance collaboration between the engineering and physical sciences communities and the biomedical research community by encouraging new collaborations and supporting existing ones. This enhances the NCI's mission by encouraging promising research projects related to the causes, prevention, diagnonsis and treatment of cancer.